NIAAA Repository/Screening Database Management and Research

As of this report, the NIAAA Repository/Screening Database includes phenotype and/or genomic data on 3100 individuals. Phenotype data include psychiatric diagnoses, a variety of alcohol-related assessments and measures including lifetime and recent consumption and alcohol response phenotypes, personality and impulsivity measures, depression and anxiety symptoms, current and early life stress and trauma, aggression, suicidality, smoking, IQ, sleep quality, pain, and overall quality of life. Laboratory/biochemical measures are also available. Genomic data include 1) large-scale single nucleotide polymorphism (SNP) genotyping performed using Illumina arrays, and 2) exome sequencing of a subset of subjects, both via a partnership between the Clinical Core Laboratory of the OCD, and the Laboratory of Neurogenetics (NIAAA). All NIAAA PIs are encouraged to submit data requests in order to conduct research projects and analyses using the shared NIAAA Repository/Screening Database. Projects are logged and the status is tracked from initial request to manuscript publication. In addition, Human and Genomic data are shared via BTRIS and other mechanisms, including collaboration with NIH-supported consortia (PGC Alcoholism, ENIGMA) to ensure data sharing. I. Projects (3) resulting in manuscripts published within the past year: Phenotypic and genotypic relationships characterizing type and severity of alcohol use responses Free peptide and receptor genotype of the appetitive hormones, leptin and amylin, and their association with alcohol-related phenotypes Predictive value of anxiety scales in alcohol dependent patients II. Projects (4) resulting in manuscript submissions, revisions, or publications in press, within the past year: Inflammation, iron loading, and sleep quality in alcohol use disorder (AUD) Genetic variance in the aquaporin gene and sleep quality in AUD Binge drinking behavior as a function of risk factors for AUD Role of circadian and cannabinoid genes in Sleep and AUD III. Projects (8) with manuscripts in preparation: Reporting of adverse childhood events as a function of race/ethnicity and gender and their influence on drinking behaviors Role of current stress and perceived stress in alcohol-dependence severity and quality of life: an update to the study of childhood trauma in AUD The role of C-Reactive protein in AUD An imaging genetics study of the prepro-ghrelin and glucagon-like peptide-1 receptor gene variants in AUD Electrocardiogram and other cardiovascular indicators of at-risk alcohol drinking An Investigation into the Role of Metabolic Biomarkers in the Anticipation of Reward in Treatment Seeking Alcoholics Immunoglobulin levels in AUD and their association with comorbid major depressive disorder and chronic stress Association between dopaminergic genetic variation and IV alcohol consumption in the lab and in the field. IV. Ongoing projects (12) still in progress: Comparison of resting state functional connectivity, alcohol consumption patterns, and CASE behavior as a function of CHRNA5 genotype. Data analyses are ongoing Exome sequencing of inpatients with AUD with low and high withdrawal. Initial sequencing is complete, additional sequencing is in progress, data analyses are ongoing. Neurobiological substrates of racial/ethnic disparity in AUD: characterization of vulnerability/resilience via imaging, genetics, and biobehavioral information. Data analyses are ongoing. Characterization of drinking patterns in AUD by Timeline Follow-Back variability analysis: association with craving, other substance use, psychopathology, and alcohol-related liver conditions. Data analyses are ongoing. An evaluation of binge drinking definitions and measurement: assessing the importance of consumption duration. Data analyses are ongoing. Genetic variations in alcohol metabolism genes and alcohol-related phenotypes. Data analyses are ongoing. Analysis of weight trends and micronutrient stores in patients admitted to an inpatient alcohol rehabilitation program. Data analyses are ongoing. Association of amygdalar genes to negative emotionality in AUD and other substance use disorders. Data analyses are ongoing. Thyroid hormones, impulsivity, and severity of alcohol dependence. Data analyses are ongoing. Nicotinic alpha subunit effects on personality using confirmatory factor analysis. Data analyses are ongoing. Neurological predictors of relapse in AUD. Data analyses are ongoing. Association of delayed reward discounting performance with dopaminergic gene variation in individuals across the spectrum of alcohol use and AUD. Data analyses ongoing. V. New projects (7) initiated within the past year: Quality of life among patients with AUD and healthy controls: Examining the effects of genetics, childhood adversities, drinking histories, and lifetime suicidality Differences in Hypothalamic-Pituitary-Adrenal Axis Responses to Alcohol Withdrawal-Induced Stress in Black and White Individuals with and without AUD Positive and negative urgency in AUD Latent Profile Analysis of Impulsive and Compulsive Drinking Interactions between the UPPS-P impulsivity facets and alcohol related outcomes The impact of trauma timing and load on brain-behavioral measures of AUD Sleep and impulsivity in AUD with comorbid mood disorder VI. Other Progress As a result of an established collaboration with Indiana University and the Centenary Institute in Australia, a manuscript was published including data from the NIAAA Repository/Screening Database, looking at genome-wide association genetic risk factors for alcohol-associated liver cirrhosis. The collaboration with The Alcoholic Hepatitis Network project (AlcHepNet) is ongoing and data were shared with the group to be used in investigations of genetic variation and new treatments in alcoholic hepatitis. A new collaboration was approved with the University of Texas, Austin, to share data for a genome-wide association meta-analyses of the individual items from the Alcohol Use Disorder Identification Test (AUDIT) questionnaire.